Caspr/11-dependent immunothrombosis and neuroinflammation during SARS-CoV-2 infection

PROJECT 2 - SUMMARY
COVID-19 is caused by pulmonary infection with SARS-CoV-2 virus and has become a world-
wide health problem. More than 6 million people passed away and among the survivors, 33%
complain from symptoms that do not disappear after the acute phase of infection which is called
Long-COVID. Notably, during infection, patients with COVID-19 suffer from thrombi in the lung
and the brain which were implicated in the symptoms of long COVID. Our project will improve
our understanding for the contribution of our innate immune system to thrombus formation and
cytokine storm during SARS-CoV-2 infection in the brain and the blood circulation. We will also
test suitable inhibitors in collaboration with other projects in this Program. Together, this project
will provide novel information on immunothrombosis and brain pathology during COVID-19 that
will allow the design of new therapeutic targets.